Development of an innovative neurosurgical planning tool for awake craniotomy

SUMMARY/ABSTRACT
Brain tumors result in a disproportionate rate of cancer morbidity and mortality. Standard of care treatment
includes maximal safe surgical resection, with extent of surgical resection (EOR) representing the most relevant
prognostic factor for patient survival. Because EOR is dependent on the surgeon’s capability to distinguish
between healthy brain tissue and tumor-invaded tissue in or adjacent to brain areas that support cognitive
function, the neurosurgeon must balance clinical objectives against causing cognitive impairments. The ground
truth standard-of-care procedure to facilitate this distinction is awake craniotomy with brain mapping using direct
electrical stimulation mapping (DES). Knowing the location of specific functions with respect to real-time surgical
targets allows the clinical team to protect those functions. It is also standard of care for pre-operative behavioral
data and brain scans to be collected on all brain tumor patients. However, there is no evidenced-based platform
that allows clinical teams to choose the most sensitive task to map and measure a given brain region, or to
understand the implications for future cognitive function of removing a specific volume of brain tissue. To fill this
gap, MindTrace Technologies, Inc. is developing a cloud-based software platform to be used before, during, and
after a neurosurgical procedure to improve the process of evaluating and choosing an optimal treatment plan.
The MindTrace platform supports the administration of functional brain mapping protocols (functional
neuroimaging, DES mapping), and the pre-processing and co-registration of behavioral and neural data in the
service of optimizing the effectiveness of brain mapping during awake brain surgery. The overall goal of this
Direct to Phase II SBIR proposal is to further improve the advanced prototype MindTrace software platform and
deploy it under IRB in the context of a research study to collect prospective longitudinal data at 4 major medical
centers. Completion of these Aims will result in a commercializable product and lay the empirical and
technological foundation for the development of real-time AI-based predictive analytics, a large-scale clinical
trial, and FDA clearance. The design of the protocol proposed herein is based on written feedback from FDA
(qSub meeting) regarding the parameters of a dataset needed for successfully apply for Breakthrough Device
Designation. The dataset to be generated by this prospective study will be the empirical basis for follow on
technology development in AI/ML predictive analytics.
MindTrace is the only company to integrate correlational data (behavior, functional MRI) with the causal evidence
generated during awake brain surgery, and the comparison of post-operative neuropsychological performance
to preoperative neuropsychological performance. Commercialization of the platform deployed within the current
proposal represents a turn-key software product that integrates multiple sources of information to enable
clinicians to plan neurosurgery more effectively in support of the best postoperative quality-of-life.

Public health relevance
NARRATIVE MindTrace Technologies, Inc. is developing a cloud-based software platform to be used before, during, and after a neurosurgical procedure to generate evidence that can support the ability of surgeons to remove brain tumors while minimizing damage to critical brain regions that support everyday abilities, like talking, moving, and seeing.